Imaging Water Diffusion in the Brain and in Other Tissue

We are continuing to develop Diffusion Tensor Magnetic Resonance Imaging (DT-MRI) as a means to probe tissue microstructure and to assess and diagnose neurological and developmental disorders in vivo. DT-MRI measures a diffusion tensor of water on a pixel-by-pixel basis within tissue noninvasively. It consists of relating an effective diffusion tensor to the measured MR spin echo signal; estimating an effective diffusion tensor, D, in each pixel from a set of diffusion-weighted MR images; and calculating and displaying information derived from D. This information includes the local fiber-tract orientation, the mean-squared distance water molecules diffuse in any given direction, the orientationally-averaged mean diffusivity, and other scalar invariant quantities that are independent of the laboratory coordinate system. These scalar parameters behave like quantitative histological or physiological "stains", yet they are "developed" without requiring exogenous contrast agents or dyes. For example, the orientationally-averaged diffusivity (or Trace) has been the most successful imaging parameter proposed to date to visualize an acute stroke in progress. Moreover, we have shown that DT-MRI is effective in identifying Wallerian degeneration often associated with chronic stroke. Studies with kittens have also shown DT-MRI to be useful in following early developmental changes occurring in cortical gray and white matter, which are not possible to detect using other means. The development of a method to color-encode nerve fiber orientation in the brain by Sinisa Pajevic and Carlo Pierpaoli has allowed us to identify and differentiate anatomical white matter pathways that have similar structure and composition, but different spatial orientations. Color maps of the human brain clearly show the main association, projection, and commissural white matter pathways. They have also allowed us to perform detailed studies of the brain's structural anatomy, which previously could only be performed using laborious, invasive histological methods. Recently, in order to assess anatomical connectivity between different functional regions in the brain, we proposed and demonstrated a way to use DT-MRI data to trace out nerve fiber tract trajectories, which we called "DT-MRI tractography". This was made possible by contributions by Sinisa Pajevic and Akram Aldroubi who developed a general mathematical framework for obtaining a continuous, smooth approximation to the measured discrete, noisy, diffusion tensor field data. We have also derived the form of the parametric distribution governing the statistical variability of diffusion tensor data, and developed non-parametric (bootstrap) methods for determining features of this statistical distribution from experimental DT-MRI data. These developments have allowed us to apply powerful hypothesis tests to address a wide variety of important biological and clinical questions that previously could only be tackled using only ad hoc methods. Finally we are addressing other key methodological issues that will allow us to perform quantitative longitudinal and multi-center DT-MRI studies. In particular, Gustavo Rohde has been developing methods to warp and register diffusion weighted images, and DT-MR images from different subjects. Collectively, these developments are enhancing the utility and broadening the scope of the clinical and reseearch applications of DT-MRI.